Optimizing an Adaptive Self-care Support Intervention for Adults with Type 2 Diabetes Leveraging their Social Relationships

Project Summary/Abstract
Successful management of type 2 diabetes (T2D) requires daily self-care behaviors which largely occur within
the context of patients’ social relationships. Chronic diseases, like T2D, have high levels of heterogeneity in
response to self-care support interventions, suggesting a sequential, individualized approach may maximize
benefits for the largest proportion of patients. Adaptive interventions mirror clinical care by applying a series of
“if-then” decision rules that dictate which intervention components are delivered over time, according to how
individuals respond. They are especially well suited to the management of chronic conditions. To date, all
adaptive interventions for chronic disease management are delivered individually; none have involved social
support. Adaptive interventions leveraging social relationships could reduce heterogeneity in response to self-
care support interventions and better meet the needs of adults with T2D. During this K23 award, the principal
investigator (PI) will address these gaps in the extant literature while participating in a mentored training
experience that will prepare her for success as an independent investigator who develops and tests adaptive
interventions to improve the health and well-being of adults with T2D by leveraging the power of social support.
Specific training goals include: (1) deepen knowledge in behavioral diabetes research, (2) develop skills in
qualitative and mixed methods, (3) apply Multiphase Optimization Strategy (MOST) framework to develop and
optimize adaptive interventions, and (4) lead a clinical trial and strengthen responsible conduct of research
skills. The proposed research includes two specific aims. Aim 1: The PI will adapt components of an evidence-
based family-focused self-care support intervention to target peer-support rather than family-support. Adults
with T2D (n=30) will be recruited to participate in focus groups and iterative rounds of testing to refine the peer-
support components prior to evaluation. A community engagement studio will advise protocols and recruitment.
Aim 2: The PI will recruit and randomize 60 adults with T2D to a pilot sequential multiple assignment
randomized trial (SMART) to test the acceptability and feasibility of random assignment to multiple social-
support focused interventions. The PI will report on the feasibility and acceptability of this innovative approach
to adaptive interventions as well as conduct interviews with participants to further improve the interventions
through a robust mixed-methods evaluation. Improvements, if needed, will be made prior to proposing a fully
powered SMART to optimize the adaptive interventions. At the conclusion of this work, the PI will have robust
preliminary data on the feasibility and acceptability of optimization methodology in adults with T2D, namely
multiple randomizations to social support-focused interventions, to inform a R01-funded SMART. This unique
expertise will accelerate the PI’s independent research career as an expert in adaptive interventions for adults
with T2D. Moreover, it will help the PI reach her ultimate goal of developing and testing adaptive interventions
to improve health and well-being of adults with T2D leveraging their social relationships.

Public health relevance
Project Narrative Adaptive interventions seek to provide the right intervention to the right person, thereby maximizing benefits and minimizing waste; however, evidence is needed to inform delivery of adaptive interventions at the social context (versus individual) level. This K23 award will innovate by testing multiple social support interventions (family and peer) and establishing the feasibility and acceptability of the protocol and adaptive interventions for adults with T2D. Moveover, completion of this work will provide a mentored experience to fulfill the principal investigator’s goals to gain expertise developing and optimizing diabetes self-care interventions leveraging social support.